Graph theoretical approach to study molecular evolution

This project focuses on graph theoretical study of molecular evolution. Particular interests include developing graph theoretical methods, models, and algorithms for study multidomain proteins, protein-protein interactions and other biological networks.